MOLECULAR RECOGNITION OF LIPIDS AND LIPOPHILES BY CYCLODEXTRIN DERIVATIVES

Hydroxypropyl cyclodextrins, chemical derivatives of glucose oligosaccharides, which were originated in the section, form water soluble complexes with lipophiles. Since these derivatives are also non-toxic they have been used as drug solubilizers with enough of success to qualify them for consideration to be included in the next edition of US Pharmacopea/National Formulary. The present chemical results point out the structural elements which are critical for the acceptable performance of hydroxypropyl cyclodextrins in biomedical applications. The present biological results point to a possible health hazards which may result from the ingestion of very large doses of hydroxypropyl cyclodextrins.